Generation and Validation of a Conditional Circadian Reporter Mouse

Most aspects of physiology have 24-hour rhythmicity. The master clock regulating circadian physiology and behavior is located in the brain, in the suprachiasmatic nuclei (SCN). Other tissues also generate rhythms of gene expression and have near-24-hr rhythms in function. An enduring question in the field is how the rhythmicity in different cells and tissues is coordinated. There is a significant unmet need for lines of mice that allow monitoring of circadian rhythms in specific tissues and cell types. The objective of this proposal is to generate and validate two novel lines of mice expressing luciferase in a rhythmic manner. In one line of mice, luciferase expression will be conditional on Cre recombinase and in the other line, luciferase is expressed in a non-conditional way. These lines will be generated by modifications of the highly rhythmic and widely expressed gene encoding albumin D-element binding protein (DBP). Our proposed studies will characterize these reporter lines for utility in generating bioluminescence rhythms in a variety of tissues, including liver, pancreas and brain, will verify the Cre-dependence of luciferase activity in the Cre-dependent line, and will verify that the genetic targeting event does not alter behavioral or molecular rhythmicity of the animals bearing it, as necessary for this to be a useful circadian reporter. We anticipate these lines of mice will be valuable to many investigators studying circadian rhythms in brain and peripheral tissues, and will facilitate studies of the desynchrony among tissues that occurs following shifts of the light-dark cycle. Once validated, these lines of mice will be distributed to qualified investigators directly and via the Jackson Laboratories repository.

Public health relevance
Shift work with circadian rhythm disruption is associated with an increased incidence of adverse health outcomes, including obesity, increased incidence of cancer, cardiovascular disease, and stroke. These pathophysiological outcomes are due to discordance between environmental timing signals and circadian clocks residing in the brain and peripheral organs. Rodent studies into this loss of coordination require monitoring rhythmicity in peripheral tissues and in brain. Studies of the brain region critical for circadian rhythm generation would also benefit from cell-type- specific rhythm monitoring. In this project, we will develop two new mouse models for monitoring circadian gene expression changes. One line allows this monitoring to be focused in a cell- and tissue-specific manner. These mice will be broadly useful for addressing mechanisms of circadian rhythm generation and re-setting in vivo and in vitro.